Connecting AMD SNPs to Functions Using Allele-specific Interactions

PROJECT SUMMARY.
Age-related Macular Degeneration (AMD) is a retinal neurodegenerative disease that is a major cause of vision loss
among the elderly worldwide. Although anti-VEGF treatments can be effective in the treatment of the neovascular
(“wet”) form of the disease, there are no proven and approved treatments for the more common atrophic (“dry”) form
of the disease. Greater understanding of the genetics and disease mechanisms underlying AMD has the potential to aid
in the development of more effective treatment strategies. Genomewide association studies (GWAS) have identified a
large number of single nucleotide polymorphisms (SNPs) that are associated with increased risk of AMD. Although these
GWAS studies have led to increased interest in the role of the complement system in AMD, the molecular mechanisms by
which AMD risk alleles lead to increased risk for the disease are poorly understood. Understanding AMD risk SNPs is
particularly challenging because most of them occur in non-coding regions of the genome. As one approach to this
problem, expression quantitative trait loci (eQTLs) studies can identify SNPs that are likely to modulate downstream gene
expression. However, eQTLs do not provide information on SNP-binding proteins. Determining intersecting GWAS
SNPs with transcription factor (TF) binding sites by chromosomal immunoprecipitation sequencing (ChIP-seq) is another
useful approach to identify functional SNPs and their interacting TFs, but this approach requires a priori knowledge of the
relevant TFs. In this application, using an approach that has not, to our knowledge, been previously applied to AMD
research, we propose to implement a Proteome-Wide Analysis of disease-associated SNPs (PWAS) study of non-protein
coding region SNPs to identify allele-specific protein-DNA interactions and alteration of regulatory activity in AMD. The
rationale for this approach is our hypothesis that functional AMD-related DNA SNPs likely execute their function via
allele-specific interactions with specific proteins. We will survey the entire human TF and RNA-binding protein
repertoires with SNP-carrying DNA probes using a protein array-based approach in which greater than 1,700 human
transcription factors (TFs)/DNA binding proteins can be simultaneously surveyed for each probe. Identified allele-specific
protein-DNA interactions will be prioritized using a series of bioinformatics analyses and validated using human retinal
pigment epithelial (RPE) and photoreceptor (PR) cells differentiated from human stem cells. In Aim 1 we will identify
TFs that show differential binding to allele-specific AMD-associated SNPs. Aim 2 will biochemically characterize and
prioritize the TFs identified in Aim 1. Aim 3 will functionally characterize the identified AMD-SNP allele-specific protein
interactions in AMD-relevant cell types, and explore how they affect cell behavior and response to AMD-related stressors.
Taken together, we hope that these studies will provide new therapeutically relevant insights in the mechanisms
underlying the development and progression of AMD.

Public health relevance
PROJECT NARRATIVE. Identification of genetic risk factors associated with Age-Related Macular Degeneration (AMD) has thus far outpaced the investigations into the biological consequences of the identified genetic variants. This project aims to take an unbiased approach to survey the interactions of over 100 genetic variants associated with AMD with the human transcription factor proteome, which may lead to novel mechanistic insight and provide a new platform to study genetic risk.